Predoctoral Training in Molecular Biophysics

This proposal requests funding for an NIH Training Program in Molecular Biophysics (the MBTP) at the
University of Wisconsin-­Madison. The MBTP trainees are a highly sought cohort of graduate students
combining strength in mathematics and physical science with a genuine interest in complex biological
systems. As students in our Biopyhysics Graduate Degree Program, MBTP trainees have a shared learning
experience and benefit from a cohesive and collaborative scientific community. The selection and recruitment
processes place special emphasis on recruiting students from diverse groups and have demonstrated marked
improvement on this metric. The BGDP has 44 affiliated trainer labs that cover most areas of experimental and
computational biophysics. These labs are spread among multiple departments and colleges, enabling the
trainees to draw on a broad range of scientific input, and explore a broad range of opportunities for research.
Our current trainees have a mean GRE Quantitative percentile rank of 79. The key elements in the training
program are core coursework that ensures that all trainees have a firm grounding in physical and
biological principles;; strong, interdisciplinary research at the forefront of molecular biophysics;; rigorous
training in quantitative approaches, experimental design, and biophysical techniques;; coursework and
informal training in responsible conduct of scientific research;; and close interaction with a
thesis/mentoring committee that is formed in the second year and maintains a strong connection with the
trainee throughout the Ph.D. program. The UW-­Madison offers a tremendous range of seminars, poster
sessions, and auxiliary coursework that greatly enhance the scientific breadth of our trainees.
A high ratio of our trainees complete their Ph.D. training, with productive output measured by publications
arising from their research and progression to their next positions in academia, industry and other professions
requiring a solid scientific background. To continue to train scientists with a strong foundation in molecular
biophysics, we are requesting support for six predoctoral training positions.

Public health relevance
There have been tremendous advances in the treatment of human disease and health related quality of life issues. At the same time, many challenges remain and the promise held by today’s understanding requires well- trained researchers that will drive tomorrow’s advances. The goal of the Molecular Biophysics Training Program at the University of Wisconsin- Madison is to provide a training environment that produces young scientists to meet the challenges.